Point of Care maternal milk concentration device to optimize neonatal growth with targeted nutrition support

Project Summary
This is an innovation that embodies the NIH mission of improving healthcare outcomes by providing
preterm infants the valuable nutrients only found in mother’s milk increasing their chance of survival
and improved overall health. The goal of this research is to tailor the technology to the specific needs of
the NICU and prove superior performance in decreasing feeding intolerance and increasing growth
through two preclinical evaluations. Human milk is the best feeding option for preterm infants.
However, to meet the high nutrient needs of preterm infants in Neonatal Intensive Care Units (NICUs),
mother’s own milk is often mixed with bovine milk sourced fortifiers to achieve nutrient level goals. This
is done despite the bovine sourced fortifiers potential to increase risk of dangerous feeding intolerance,
to negatively impact immune system, microbiome development and even long-term health by
increasing risk of lung and eye diseases. These risks along with the breakdown of the infant formula
supply chain make it an urgent need to find an alternative safer and more available method. The Human
Milk Concentration (HMC) device is a safe and simple solution- it uses a passive osmotic process to
remove some of the water from milk so that preterm infants can receive optimal nutrients from their
own mother’s milk without cow’s milk additives and helps support breast feeding moms providing an
alternative to moving straight to formula. The success of the work will further bring convincing evidence
of the safety and efficacy of this technology supporting the final development phase of the membrane:
preparing for FDA submission, submission and finally clinical testing. Mother’s Milk Is Best Inc (MMIB)’s
Phase II objectives are to 1) create an HMC formulation and casting process specific for a medical device
application 2) Design and test 2 product embodiments for specific use cases and 3) perform pre-clinical
tests to determine the impact of feeding concentrated HM to neonatal gut cell derived enteroids 4)
Compare growth metrics and gut health in mice fed concentrated milk, unconcentrated milk and
formula. Once the membrane formulation has been tested and fabrication process set per medical
device and HMC requirements, MMIB will be confident in the safety and efficacy of the device thus
advancing the technology one step toward use of the HMC in the NICU and milk banks to help preterm
infants thrive.

Public health relevance
The Human Milk Concentration (HMC) device will allow for the exclusive use of mother’s own milk when nourishing vulnerable preterm infants in need of high nutrient intake. The ability to fortify feedings with mother’s own milk, allowing the transfer of vital nutrients found only in mother’s milk to the child, can reduce illness and improve overall long-term health benefits for preterm infants.